Elucidating the role of luminal pH in regulating phagosome transport

Project Summary/ Abstract
Macrophages capture harmful microbes by engulfing them and forming dynamic organelles called phagosomes.
Following internalization, phagosomes undergo a graded process known as phagosome maturation. This
involves the phagosome being transported by motor proteins along microtubules from the cell periphery to the
lysosomes in the perinuclear region. During transport, the nascent phagosome sequentially fuses with early and
late endosomes, leading to a gradual acidification of the phagosome lumen. Various pathogens, including
Mycobacteria, Salmonella, Candida, and others, employ strategies to subvert or adapt to the acidic phagosomal
pH, which can have serious consequences for human health. The roles of luminal pH in phagosome function
and the factors that regulate phagosomal pH are not yet fully understood. Our recent study revealed a surprising
new role for phagosomal pH in governing the transport of phagosomes and identified the sodium proton
exchanger NHE9 as a regulator of phagosomal pH. Our long-term objective is to understand how the
phagosomal environment impacts motor protein activity, to devise novel approaches for combating pathogens
evading the acidic phagosome. NHE9 hinders the directed motion of phagosomes along microtubules and
promotes early detachment from the microtubule tracks. However, the mechanism by which NHE9-mediated
changes in pH within the phagosome lumen alter phagosome transport is not yet known. This application aims
to achieve two objectives: first, to uncover the mechanism that links NHE9-mediated luminal pH regulation to
phagosome motility, and second, to characterize the effect of this regulation on the mechanics of microtubule-
associated motor transport. Dynein and kinesin motors both drive phagosome transport, but their opposing
forces create a tug-of-war. Membrane lipids could play a crucial role in regulating this process by selectively
determining which class of motors binds to phagosomes, tipping the balance in favor of one direction over the
other. Specifically, phosphatidylinositol-3-phosphate (PI3P) on early phagosomes and cholesterol on late
endosomes, are vital for motor protein recruitment and activity. Previous studies indicate luminal pH impacts
both PI3P and cholesterol levels. Our central hypothesis is that luminal pH changes mediated by NHE9 are
communicated to the motor proteins via the membrane lipids. We will test our hypothesis through the following
aims: In aim 1, we will investigate the impact of NHE9 expression on PI3P and cholesterol levels on phagosomes,
as well as the recruitment of motor proteins on these membranes. Luminal pH measurements will be conducted
in conjunction with these experiments. In aim2, we will elucidate the impact of NHE9-mediated luminal pH
changes on the mechanics of bidirectional motion. This research is significant as it will unveil the mechanism by
which luminal acidification regulates phagosome transport, a crucial process for effective pathogen elimination.

Public health relevance
Project Narrative Macrophages, a type of immune cells, capture microbial pathogens in vesicles known as phagosomes, which are gradually filled with acid as they move towards the center of the immune cell where they fuse with another vesicle known as the lysosome for pathogen elimination. The goal of our proposal is to elucidate how the acid in the phagosome lumen governs the transport of the phagosome. Pathogens that cause severe diseases in humans employ various mechanisms to subvert phagosomal acidification, and therefore insights gained from this study will have significant implications for developing effective methods to combat these highly dangerous microbes.